Non-Fracture Fall Injuries and Long-Term Geriatric Consequences in Older Women and Men from a Cross-Cohort Study

Project Summary/Abstract
The goal of this R01 application is to examine time trends for incident fall injuries in Medicare, including non-
fracture fall injuries (NFFI) and fractures, across 20 years of cohort data and if changes in risk factors explains
trends, and then to evaluate major geriatric outcomes subsequent to incident NFFI. Unlike osteoporotic
fracture, NFFI - defined as fall injuries without fracture - are not treated as hallmarks of geriatric decline,
particularly if the presenting injury is not severe (e.g., soft tissue injury). Our preliminary data found fall
mortality in older adults increased substantially over the past several decades, with higher increases for the
oldest cohorts. We will evaluate if this trend in fall mortality extends to non-fatal medically treated fall injuries
over 20 years in several combined epidemiologic cohorts of older adults with overlapping time periods from
1998-2019. The Specific Aims are: 1) To examine time trends for incident fall injuries in Medicare, including
NFFI and fractures, across 20 years of cohort data and if changes in risk factors over the time period explains
trends; and 2) To determine if incident NFFI predict future inpatient hospitalizations, increased risk of SNF
stays and mortality for up to 5 years after NFFI in women and men. In 4 pooled longitudinal cohorts (61%
women, 33% minorities, 36% aged >80 years, 27% obese) with in-person exams of 4,653 men and 7,338
women, incident fall injuries will be identified from 5-10 years of self-reported questions and Medicare Fee for
Service (FFS) Parts A and B claims. We hypothesize fall injury incidence will increase over time in the
combined cohort of nearly 12,000 women and men, with increases higher at the oldest ages, and that overall
fall injury incidence and NFFI incidence increases will be partially explained by risk factors of metabolic (e.g.,
obesity, diabetes, blood pressure) and neuromuscular function (strength, gait speed, chair stand speed) that
we have identified in past work as novel risk factors for NFFI. We hypothesize that an estimated 1,867 incident
NFFI will predict future inpatient hospitalizations, increased risk of SNF stays and mortality. Our validated
approaches from past projects combine extensive cohort data across 20 years and linked Medicare claims to
examine increasing trends in fall injuries, including clinical NFFI, as a significant public health issue in old age.

Public health relevance
Project Narrative The goal of this R01 application is to examine time trends for incident fall injuries in Medicare, including non- fracture fall injuries (NFFI) and fractures, across 20 years of cohort data and if changes in key risk factors of metabolic and neuromuscular function over the time period explains trends; and then evaluate major geriatric outcomes subsequent to NFFI in a pooled cohort of nearly 12,000 older adults (61% women, 33% minorities, 36% aged >80 years, 27% obese). Incident fracture and NFFI, defined as fall injuries without prior fracture, will be identified from 5-10 years of self-reported questions and Medicare Fee for Service (FFS) Parts A and B claims; and then incident NFFI will be related to subsequent inpatient hospitalizations, skilled nursing facility (SNF) stays and mortality for up to 5 years after NFFI. Our validated approach from past projects will pool extensive cohort data and Medicare claims to evaluate fall injury trends, including clinical NFFI, as a public health issue in aging.